NONCODING CONSTRAINT ON DNA AND GENE REGULATION

A substantial fraction of vertebrate mRNAs contain long conserved blocks in their untranslated regions as well as long blocks without silent changes in their protein coding regions. These conserved blocks are largely comprised of unique sequence within the genome, leaving us with an important puzzle regarding their function. A large body of experimental data shows that these regions are associated with regulation of mRNA stability. Combining this information with the rapidly accumulating data on endogenous antisense transcripts, we propose that the conserved sequences are the result of a trans-allelic interaction possibly involving duplexes between the transcript of one allele and the counter-transcript of the other allele. The formation of such duplexes may be essential for recognition by ost-transcriptional regulatory systems. The conservation may then be explained by selection against the dominant negative effect of allelic divergence. - antisense post-transcriptional regulation